Advancing the Treatment of Alcohol Associated Liver Disease by Precision Targeting Methyltransferase-like Protein family

Project Summary/Abstract
Alcohol-associated liver disease (ALD) progresses from fatty liver to severe stages like alcoholic steatohepatitis,
fibrosis, and cirrhosis. Despite its common occurrence and significant health impact, there are no approved drugs
for ALD. Our primary objective is to uncover therapeutic targets and develop effective treatments for ALD. Fatty
liver in ALD is characterized by the accumulation of lipid droplets (LDs) and is closely associated with genetic
variant mutations including PNPLA3-I148M variant. Our research focuses on a group of human enzymes called
methyltransferase-like (METTL) proteins, notably METTL7A, is highly expressed in healthy human livers and
significantly upregulated in ALD patients, particularly phosphorylated at serine 53 (hMETTL7A-S53). This
elevation significantly correlates with the severity of steatosis, inflammation, and fibrosis. Furthermore, our
analysis suggests an interaction between hMETTL7A-S53 and PNPLA3-I148M variant. Knockdown of
hMETTL7A or inactivation of hMETTL7A-S53 reduces ethanol-induced lipid accumulation and PNPLA3 levels,
supporting its role as a precision therapeutic target for ALD. We hypothesize that targeting hMETTL7A-S53 and
its association with PNPLA3-I148M is an effective approach for ALD treatment. Our approaches utilize cutting-
edge technology and human hepatocytes to study the protein interactions, and FDA-approved liver-specific RNAi
and AAV-based gene delivery. We will assess the effectiveness of two formulations to treat ALD including
GalNAc-siRNA-METTL7A conjugates to inhibit hMETTL7A, and AAV7-hMETTL7A-S53A (Serine 53 is replaced
by Alanine) to deactivate hMETTL7A phosphorylation. Aim 1 Determine the mechanism of hMETTL7A
interaction and stabilization of PNPLA3-I148M and evaluate the manipulation of this interaction for therapeutic
benefits in ALD. Aim 2 Test the therapeutic efficacy of the two formulations in both the prevention and reversal
of ALD. The goal of this project is to establish hMETTL7A as a promising therapeutic target for the precise
treatment of ALD, particularly in cases associated with PNPLA3-I148M variant. This initiative represents an
innovative investigation into METTL proteins, with the aim to leverage their potential for advancing clinical
interventions in ALD treatment.

Public health relevance
Narrative This application will establish hMETTL7A as a promising therapeutic target for the precise treatment of ALD, particularly in cases associated with PNPLA3-I148M variant. This initiative represents a novel exploration within the field of METTL proteins, aiming to leverage their potential for advancing clinical interventions in ALD treatment.